Large-scale transcriptome and epigenome association analysis across multiple traits

PROJECT SUMMARY
Precision Psychiatry is an emerging approach that considers patients’ characteristics to customize prevention
and treatment for serious mental illness. The Million Veteran Program (MVP) is the largest and most
comprehensive biobank in the world, currently involving multi-ancestry genetic data from more than 650,000
Veterans and highly dense electronic health record information that fully captures the clinical characteristics of
each participant. Given the high prevalence of serious mental illness among our Veterans, MVP provides a
unique opportunity to perform large-scale genetic discovery that will further our understanding of the
pathophysiology of serious mental illness and promote Precision Psychiatry. While well-powered genome-wide
association studies (GWAS) have identified multiple risk variants across serious mental illness, there have been
limited conclusive findings on the functional relevance of most discovered loci due to small effect size, overlap
with non-coding regions of the genome and unclear mechanisms through which they act. Our group and others
have shown that a large portion of phenotypic variability in disease risk can be explained by regulatory variants
with cell type specificity, i.e. genetic variants that affect epigenetic mechanisms and the expression levels of
genes. Studying gene expression and epigenome changes directly in MVP samples is not feasible as such data
are not available. To overcome these limitations, we propose to take advantage of large-scale datasets with
genotyping and multiscale molecular profiling that our group and others have generated in human brain tissue
and apply machine learning approaches to directly impute genome-wide transcriptomes, epigenomes and
proteomes in MVP samples using the existing MVP genotypes. The primary goals of our project are threefold:
First, imputed MVP transcriptomes, epigenomes and proteomes will be meta-analyzed to single tissue-specific
gene dysregulation scores for each individual via a novel method, called PolyXcan, which leverages a data-
driven correlation-aware meta-analytical framework and performs joint multi-omics-wide association studies. For
each serious mental illness, key gene drivers and molecular pathways will be identified with a structured,
interpretable deep learning approach and gene-gene interaction effects by leveraging patient subtypes identified
with semi-supervised graph-based cluster methods; both of these approaches are only possible with well-
powered individual-level (genotypic and phenotypic) data of the scale that exists in MVP and we expect them to
enhance efforts for gene target prioritization and drug discovery. Second, imputed gene dysregulation for each
individual in MVP will be integrated with perturbagen reference libraries (describing the effect of therapeutic
compounds on gene expression) to identify the extent to which compounds could be therapeutic by antagonizing
the predicted gene dysregulation. We have validated this approach to summary level data (from GWAS) in a
wide range of disorders (autoimmune, neuropsychiatric and COVID-19). Here we propose to use the same
approach at the individual level to determine whether genetics can be utilized to rank potential treatments and
predict the ones that achieve better outcomes. Third, the scale of data generation and its integration into
predictive models will provide a wealth of data that will be made available to the MVP scientific community for
other diseases beyond the immediate goals of this proposal that have the potential to increase our understanding
of Precision Psychiatry. Successful completion of our study would have an enormous impact on our Veterans
since, in addition to the tremendous burden of suffering and economic costs, serious mental illness increases
the mortality rate among Veterans.

Public health relevance
PROJECT NARRATIVE The Million Veteran Program (MVP) constitutes the largest and most comprehensive biobank in the world, including multi-ancestry genetic data from more than 650,000 Veterans and dense electronic health records that fully captures the clinical characteristics of each participant. MVP provides a unique opportunity to perform large- scale genetic analyses and further our understanding of Precision Psychiatry across multiple traits and diseases. Here, we propose to leverage MVP data, integrate them with brain molecular profiling data, and perform a comprehensive analysis to investigate the functional roles of variants associated with serious mental illness that affect a great proportion of our Veterans. In addition to the tremendous burden of suffering and economic costs, these diseases increase the mortality rate among Veterans. Thus, this study is aimed at addressing the need for understanding the pathophysiology, identifying key drivers, and testing novel approaches to genetically informed customized treatment or prevention tailored to the individual characteristics of each patient.